Develop High-Precision and Multiplex Base Editing Approaches for Therapeutic Applications

Project Summary/Abstract
Genetic disorders and genetic diseases are caused by insertions, deletions, and base substitutions of a single
gene or multiple genes. Cystic fibrosis (CF), an autosomal recessive hereditary disease, is caused by mutations
of the cystic fibrosis transmembrane conductance regulator (CFTR) gene. In healthy cells, CFTR maintains
chloride and bicarbonate transportation as an ion channel. Genetic defects of CFTR result in complicated
respiratory and systemic organ failure. Point mutations, or single-nucleotide variations (SNVs), account for ~60%
of the pathogenic variants causing CF. CF patients can be partially treated by the administration of small
molecule drugs to improve symptoms, including chronic pulmonary disease and pancreatic insufficiency.
However, CF mutations leading to the premature termination codon (PTC) affect at least 10% of CF patients,
whose symptoms cannot be relieved by any of the modulators. Gene therapy is a promising and permanent
alternative approach that confers therapeutic benefits to patients who suffer from genetic diseases. The CRISPR-
Cas9 system can efficiently cause double-strand breaks (DSBs) to facilitate homology-directed repair (HDR) for
accurate gene-editing outcomes. However, safety concerns arising from the DSBs cause unwanted mutations.
To surmount this problem, base editors (BEs) use a nickase Cas9 (nCas9) that nicks only the protospacer
adjacent motif (PAM)-containing strand, and thus eliminates the risk of DSBs and random indels. BEs use a
natural or engineered DNA deaminase fused with a nCas9 and can introduce a C-to-T or an A-to-G conversion
within the activity window by the cytosine or adenine deaminase. Both cytosine BEs (CBEs) and adenine BEs
(ABEs) can enable base transitions with high efficiency and have already proven successful for a few genetic
diseases in proof-of-concept studies. However, before applying BEs to the treatment of human genetic diseases,
including CF, several challenges must be overcome. First, indiscriminate conversion of multiple ‘C’s or ‘A’s within
CBE or ABE’s characteristic deamination activity window, usually more than five nucleotides, results in undesired
bystander editing. Second, the targeting scope of BEs has been largely constrained by the NGG PAM
requirement of nSpCas9, the canonical Cas9 from Streptococcus pyogenes. A large proportion of the base
transition pathogenic mutations is thus unavailable for editing. Third, the lack of multiplexity of BEs impedes its
practicality in processing multiple mutations simultaneously for the treatment of complex genetic diseases. In
this proposed research, we aim to develop precise and multiplex BEs that will make it possible to target the vast
majority of human genome sites (Aim 1 & 2). We will apply high-precision BEs to generate and correct
homozygous and compound heterozygous CF disease models that mirror individual patients, which will also
greatly facilitate pharmacological research and drug discovery for personalized CF treatment (Aim 3). In
summary, high-precision BEs will contribute to personalized gene therapy for cystic fibrosis as well as many
other genetic diseases.

Public health relevance
Project Narrative The proposed research will develop the next-generation of high-precision and multiplex base editors to provide an alternative and promising approach for the treatment of human genetic diseases. The advanced base-editing tools will not only greatly benefit the mechanistic study and treatment of cystic fibrosis, an autosomal recessive hereditary disease, but also contribute to other human genetic disorders and fundamental biomedical research.